LATC Collaborative Projects

The Nonhuman Primate Testing Center for Evaluation of Somatic Cell Genome Editing Tools supports studies with nonhuman primates that will advance the genome editing field, and significantly contributes to the future translation of these technologies for the treatment of human disease. The Nonhuman Primate Testing Center includes a robust team and partnerships that capitalize on major strengths including the California National Primate Research Center, Genome Center, and Clinical and Translational Science Center. The Nonhuman Primate Testing Center offers state-of-the-art capabilities for Somatic Cell Genome Editing (SCGE) awardees to conduct high quality research in nonhuman primates. The Testing Center leverages a supportive framework that has demonstrated a long-standing commitment to providing research opportunities and collaborations to investigators nationwide. Through this powerful infrastructure the Testing Center fosters partnerships with SCGE awardees through provision of expertise, resources, and collaborative opportunities that accelerate their research, and ensures synergism across the SCGE Consortium and with ongoing interactions with the Dissemination and Coordinating Center. This supplement supports projects for investigators funded through the Consortium and will provide all of the benefits and capabilities of the Nonhuman Primate Testing Center for Evaluation of Somatic Cell Genome Editing Tools.

Public health relevance
The Nonhuman Primate Testing Center for Evaluation of Somatic Cell Genome Editing Tools serves the Somatic Cell Genome Editing community and the public by supporting studies in nonhuman primates that will advance the field. Through these efforts the Nonhuman Primate Testing Center will significantly contribute to the future translation of cutting-edge technologies for the treatment of a range of rare and common human diseases.